Chemoproteomic discovery and functional analysis microbiota bile acid-protein targets in host immunity

PROJECT SUMMARY
Key metabolites from intestinal microbiota can modulate host immune responses, but their mechanisms of action
are unclear and limit the development of new therapeutic approaches in human health and disease. To determine
the mechanism(s) of action of prominent microbiota metabolites (short chain fatty acids, aromatic amino acids,
bile acids and others), multi-disciplinary approaches are needed to biochemically identify metabolite-protein
targets in mammalian cells and characterize their activity on host immunity in vivo. For this grant application, our
laboratories will focus on microbiota-associated bile acids and employ innovative methods in chemical biology
and proteomics to identify their protein targets in mammalian cells and characterize their mechanism(s) of action
on host immunity in vitro, ex vivo and in mouse models in vivo. A better understanding of how these microbiota
metabolites affects host immunity should reveal potential therapeutic targets and facilitate the development of
therapeutic approaches against infection and cancer in animals and humans.

Public health relevance
PROJECT NARRATIVE Metabolites from microbiota can modulate host immunity, but their mechanisms of actions have not been fully elucidated. Using innovative chemical biology and proteomic methods, we will determine the protein targets of prominent microbiota metabolites (bile acids) and evaluate how they modulate specific host immunity responses. Understanding how the key microbiota metabolites affects host immunity should afford new therapeutic approaches towards infection and cancer.